PILOT STUDY--DETECTION OF EARLY CNS MANIFESTATIONS OF HIV WITH HEMOPHILIA

The purpose is to test the hypothesis that CNS manifestations are one of the earliest manifestations of HIV infection; and those seropositive children without opportunistic infections may already have widespread CNS involvement.